Project 6 - Development of Antivirals against Alphaviruses

Alphaviruses are enveloped plus-sense RNA viruses that include a number of important human pathogens such
as the arthritogenic alphaviruses chikungunya virus (CHIKV), Mayaro virus, and Ross River virus, and
encephalitic alphaviruses such as Eastern and Venezuelan equine encephalitis viruses. These viruses have
emerged as world-wide public health and/or biodefense threats, but to date there are no licensed vaccines or
antiviral therapies. Project 6 in the AC/DC seeks to develop orally available direct-acting antivirals against
alphavirus infection. We focus on targeting the RNA replication complex, which is formed by the coordinated
activities of the four alphavirus non-structural proteins (nsP1-4). Promising preliminary data with our existing
chemical assets demonstrate inhibition of CHIKV RNA replication by nucleosides and by inhibitors of the
essential protease activity of nsP2. Moreover, prophylactic treatment of mice with our ribonucleoside EIDD-2749
prevented CHIKV viremia and disease. We will build on these findings through the following Aims, in close
collaboration with the AC/DC Cores:
1. Optimize and characterize inhibition by the previously identified nucleoside inhibitors EIDD-2749, EIDD-
2997, and additional prodrugs/analogs developed from AC/DC SAR studies. We will define their mechanism of
action using our panel of available protein, cell-based, and virus infection assays. We will determine the breadth
of inhibition across other alphaviruses and determine resistance profiles and effects on virus replication in cell
culture.
2. Perform high throughput screening for inhibitors of CHIKV RNA replication using a cell-based replicon
reporter system. Hits will be progressed to preclinical development in collaboration with Cores B and C, and
mechanisms defined as in Aim 1.
3. Optimize and characterize inhibitors of the nsP2 protease. We will optimize and further develop our initial
inhibitors of nsP2 protease, and use a cell-based screen to identify additional nsP2 protease inhibitors. We will
define their mechanisms by using cell-free nsP2 enzymatic assays and virus infection, as well as by applying
the strategies described in Aims 1 and 2.
4. Characterize in vivo efficacy. We will use established mouse models to determine the in vivo efficacy of
EIDD-2749 and early leads from Aims 1-3 against acute and chronic CHIKV infection and disease. We will also
develop a novel reporter mouse line with an integrated alphavirus minigenome template that can detect
alphavirus-mediated RNA replication with high specificity and sensitivity. This strategy will be used to follow
infection by unmodified alphaviruses, to identify target cells during the acute and chronic phases of CHIKV
infection, and to evaluate antiviral therapies developed in this proposal.